Core A: Administrative Core

PROJECT SUMMARY (Core A: Administrative Core)
The overarching goal of the Stanford/UNC Biomimetic U19 Research Center Administrative Core is to provide
the administrative support necessary to form a cohesive, integrated, and efficient Center. In doing so, the
Administrative Core will optimally support the Center’s goal to create in vitro model systems using optimized 3D
human organoid cultures to study human respiratory and enteric infectious diseases. The Administrative Core
will serve as a central hub for the management and coordination of all Center activities and will extend the
successful practices implemented during the current NAMSED award. We will maximize efficiency, cost-
effectiveness, and productivity by centralizing common administrative and operational resources used by each
Project and Core. The core will be led by Drs. Calvin Kuo and Manuel Amieva and will involve the Project and
Core leaders and NIAID Program Staff on a Center Steering Committee. The Administrative Core will convene
weekly subgroup meetings, monthly full meetings, monthly Steering Committee meetings, and an annual retreat
to foster collaboration and synergy. Day-to-day operations of the Administrative Core will be overseen by a
dedicated Center Manager. The Administrative Core has the following Specific Aims:
1) Provide administrative leadership and integration of projects and cores across the proposed Center via a
Management Plan.
2) Convene internal and external advisory board meetings and facilitate meaningful interactions between
advisory boards and Center members.
3) Provide an efficient, centralized unit for the fiscal operation of Center activities.
4) Establish practices to monitor project productivity and assess use of core resources.
5) Provide infrastructure support for Stanford/UNC Biomimetic U19 Research Center investigators to develop
collaborative studies with other members of the Biomimetics Consortium and with pertinent scientific
communities.
6) Coordinate and implement broad results dissemination.